Biochemistry analyzer for Oregon Veterinary Diagnostic Laboratory

Project Summary/Abstract A clinical biochemistry analyzer is an essential piece of equipment for clinical pathology laboratories that assesses the function and response to injury of key organs such as liver and kidney. Many food contaminants/misformulations, toxins, microbial agents, cancer and other conditions affect these organs and can trigger biochemical changes measured by the biochemistry analyzer. The Oregon Veterinary Diagnostic laboratory (OVDL) has an AU480 biochemistry analyzer that is now 10 years old and lived its functional life expectancy, and therefore needs to be replaced. Our laboratory cannot function for a single day without a biochemistry analyzer. The OVDL receives a widely varied diagnostic caseload from domestic animals as well as wildlife, aquatic and marine species of the Pacific Northwest. The OVDL services are vital to a variety of clients and to public health, both of which are key to Vet LIRN’s mission. A biochemistry analyzer is necessary for the OVDL to be fully operational for Vet LIRN projects and investigations.

Public health relevance
Project Narrative A biochemistry analyzer is needed for detection/measurement of alterations in the function of organs such as liver and kidney which can be injured by food contaminants/misformulations, toxins, microbial agents, cancer and other conditions. Serum and other fluids are used in the biochemistry analyzer to measure levels/function of numerous biochemical reactions. This gives clinicians, diagnosticians, owners and others insight to the degree and type of organ injury. Some items measured by a biochemistry analyzer include: hepatic enzymes (AST, ALT, ALP, GGT), levels of conjugated and unconjugated bilirubin, cholesterol, triglycerides, blood urea nitrogen (BUN), creatinine, electrolytes (sodium, potassium, chloride), minerals (magnesium, phosphorus, calcium), glucose, carbon dioxide and other analytes. Changes in these can point to general injury to liver or kidney and in some cases, direct one towards a more precise category or type of injury. We are also unique in that we have an open sourcebiochemistry analyzer and because of this, we have develop assays to measure beta hydroxyl butyric acid (BHBA) and non-esterified fatty acids (NEFA) which are used to measure metabolic conditions in cattle, goats and horses and these conditions could occur secondary to feed misformulations (e.g., grain overload) and/or toxins (e.g. urea toxicity). Hepatic, renal and metabolic injuries can occur secondary to items integral to the mission of the Vet LIRN program (e.g., food contaminant/misformulation, toxin injury, microbial infection and other conditions). Information from these tests can direct diagnosticians towards additional, more specific tests to further identify an injurious substance or agent. The Oregon Veterinary Diagnostic Laboratory (OVDL) current biochemistry analyzer needs to be replaced; it is over 10 years old and such instruments should be replaced after roughly 8-10 years. Also service contract cost are increasing as this system ages. A new biochemistry analyzer will enhance OVDL preparedness for Vet LIRN projects and investigations.